Sensory Integration for Spatial Navigation After Concussion

PROJECT SUMMARY/ABSTRACT
The reasons for persistent symptoms following a concussion, such as dizziness and imbalance, are not well
understood. While common perceptions attribute dizziness and imbalance after concussion to vestibular
problems, recent evidence points towards abnormal integration of sensory information, as measured by static
assessments (i.e., balance while standing), rather than peripheral sensory dysfunction. However, many
everyday tasks, like navigation, require dynamic central sensory integration of vestibular, visual, and
proprioceptive cues. The lack of knowledge of central sensory integration during dynamic activities leaves a
critical gap in understanding the consequences of concussion during daily life. Our central hypothesis is that
concussion alters central sensory integration required for dynamic mobility, including spatial updating and
control of balance. This exploratory proposal will begin to address the role of sensory integration in the
dynamic task of spatial updating, which is a process that is required for effective navigation and uses visual,
proprioceptive, and vestibular information to keep track of one’s location and orientation in space. Spatial
updating is a necessary component for forming an accurate cognitive map of the environment, which is crucial
for independent living. The proposed work will consider the overlap and potential interference between spatial
updating, a cognitive application of central sensory integration, and the control of balance, a motor application
of central sensory integration. The long-term goal of the work is to improve rehabilitative care for people with
persisting imbalance after concussion by directing patients to targeted treatments that improve their mobility
and navigation in daily life. As traditional rehabilitation for post-concussion imbalance focuses on sensory
integration for balance, we will use virtual reality to determine how concussion affects sensory integration
during spatial updating and how this integration relates to sensory integration for balance. In Specific Aim 1, we
will assess concussion-related differences in performance and sensory integration on an ambulatory VR spatial
updating task by varying visual and self-motion cues. In Specific Aim 2, we will determine the association
between sensory integration for dynamic spatial updating and sensory integration for balance. In Specific Aim
3, we will test the extent of dual-task interference between spatial updating and dynamic balance. Overall, our
innovative study will use state-of-the-art technology (virtual reality) to assess central sensory integration during
a dynamic spatial updating task and then relate performance on that task to the ability to control balance.
Overall, the results of this study will open a new significant line of research that can use virtual reality as an
innovative and clinically-translatable assessment, and potentially future treatment, of sensory integration for
spatial updating and sensory integration for balance in clinical settings for people with persisting symptoms
after concussion.

Public health relevance
PROJECT NARRATIVE Rehabilitation for people with persisting symptoms of imbalance and dizziness after concussion focuses on improving one’s ability to integrate sensory signals for balance control. However, daily life also requires a cognitive application of this sensory integration to remember one’s position and navigate through the environment. This project will use state-of-the-art virtual reality technology and tests of dynamic sensory integration during navigation and balance to determine the effects of concussion on spatial navigation to guide targeted rehabilitation strategies.